Training program in the biology and translational research on Alzheimer's diseaseand related dementias

Project Summary
This T32 renewal application seeks support for the multidisciplinary education of trainees in Alzheimer’s disease
and Related Dementia (ADRD). The goal of this program is to train the next generation of creative and
meritorious ADRD researchers at the predoctoral level. We acknowledge that the development of future therapy
for dementia will require strong training in multiple disciplines, such as, the molecular biology of dementia, drug
discovery and development, clinical studies and the analysis of large data sets. We will answer the imperative
need for scientists who can synthesize across disciplines. Our Training Program comprises of four
discplines/themes: (1) biological mechanisms (2) drug discovery and development (3) clinical ADRD (4)
computational science. Each student gets trained in at least two of the four disciplines, utilizing a multidisciplinary
approach for tackling scientific questions in ADRD. Attentive to the latest recommendation of the NIA and
Alzheimer’s Association guidelines, there will be special emphasize on the analysis of lifestyle, environmental
factors and preventative approaches for ADRD. The mentor/preceptor team has outstanding expertise to
establish this innovative, interdisciplinary training program, to integrate otherwise disparate centers of excellence
at UIC and Rush, leveraged by industry collaborations. Preceptor expertise is diverse; from molecular
mechanisms of dementia, vascular biology, diabetes and inflammation, neuronal and neural imaging to clinical
diagnosis of human ADRD patients and large scale data analysis. Expertise is from 12 departments and 6
clinical and translational entities. We will train ADRD researchers with diverse backgrounds and cross-
disciplinary skills, including neuroscientists, but also computational biologists, chemists, and engineers
interested in translational ADRD research. To facilitate interdisciplinary training, trainees will have two preceptors
from different disciplines. We will build individual development plans (IDPs) for each trainee and offer
multidisciplinary coursework from ADRD-TP faculty and pharma scientists. Importantly, trainees can perform
translational research at any of the affiliated clinical and translational entities. Trainees will be encouraged to
collaborate with large community-based NIH-supported studies (ROS/MAP) or NIA’s large-scale collaborative
consortia (AMP-AD, M2OVE-AD, ADNI, ACTC), and with our pharma partners, Eli Lilly, Abbott and Baxter.
Trainees are encouraged to participate in workshops geared towards -omics and drug discovery and the
CIM/MATTER entrepreneurial program that aids commercialization of scientific innovation. We seek to support
6 predoctoral trainees. The success of this program in the last five years is reflected by our alumni who have
moved on to successful careers in academia and pharma. The ADRD-TP’s vitality is reflected by the numbers
of highly qualified applicants and state-of-the-art scientific endevours and publications. We expect the next five
year to surpass this success. In summary, the ADRD-TP will provide a rigorous, inspiring and nurturing
environment to ensure training of the highest level of scientists needed to unravel dementia.

Public health relevance
NARRATIVE This training grant renewal application requests continued support for our training program in Alzheimer's disease and related dementia (ADRD-TP). The foundation of this training program is an outstanding group of preceptors who have exceptional combination of expertise that permits and promotes the multidisciplinary training of versatile ADRD researchers. The Program is composed of four integrated themes of research training: (1) Biological Mechanisms (2) Drug Discovery and Development (3) Clinical (4) Biophysics, Bioinformatics and Computational Science. In addition, the program includes collaborative training with the pharmaceutical industry in drug development and clinical trials in ADRD. This program encourages trainees to integrate and cross information, in a way that stimulates complex problem solving, required for finding a cure for ADRD.